Mitochodrial Dynamics in Metabolism-based Therapies for Epilepsy

DESCRIPTION (provided by applicant): This proposal provides a mentored career development plan and research proposal designed to facilitate the principal investigator's transition to an independent clinician-researcher. Epilepsy affects ~1.7% of the US population at some point during life and ~33% of patients have seizures that are not controlled by medication. Options for this group are limited but one treatment from antiquity, the ketogenic diet, was shown in a recent randomized trial to induce a 75% decrease in seizures in children (vs those waiting to start the diet) over three months. However, the mechanisms of the diet's anticonvulsant actions are not understood. The ketogenic diet induces major changes in metabolism. The mTOR pathway integrates multiple metabolic signals and its inhibition leads to many changes, including degradation of cellular components including mitochondria. Mitochondrial degradation also affects key neuronal processes that govern mitochondrial localization and function. Mitochondria have multiple functions in neurons, such as maintaining neuronal energy status for the maintenance of electrochemical gradients and release of neurotransmitters. Synaptic localization of mitochondria is critical for normal synapse morphology and firing. Our hypothesis is that nutrient-sensing pathways induced by the ketogenic diet lead to changes in mitochondrial dynamics and localization in specific neuron subsets. Three goals are proposed: (1) determine the role of a nutrient-sensing pathway in metabolism- based anticonvulsant therapy; (2) determine the cell-type specificity of the effects of the ketogenic diet; and (3) determine the effects of the ketogenic diet on mitochondrial dynamics, and the dependence of these effects on mTOR. These studies are expected to identify new targets for the treatment of epilepsy and unravel the mechanisms of metabolism-based therapy. This information will be valuable for the development of clinical treatments that are more effective and more convenient to implement than dietary modification. An individualized career development plan is outlined in detail. This proposal will be carried out under the mentorship of Dr. J. Marie Hardwick, David Bodian Professor at Johns Hopkins Schools of Public Health and Medicine, an expert in mitochondrial dynamics and the factors that regulate these processes. The plan utilizes the expertise of experienced collaborators and includes specific plans for relevant training. Johns Hopkins is an internationally-recognized center for Pediatric Epilepsy and is one the few institutions where different types of metabolism-based therapy in epilepsy have been implemented continuously for over 70 years. The principal investigator's long-term goal is to make significant contributions towards identifying novel targets in the treatment of medically intractable epilepsy in children. PUBLIC HEALTH RELEVANCE: Over one-third of patients with epilepsy do not respond to the available drugs. One option for these patients is the ketogenic diet, which significantly decreases seizures in one half of patients who use it. However, essentially nothing is known about the anticonvulsant mechanisms involved. This proposal pursues a potential underlying mechanism of the ketogenic diet in epilepsy and is expected to identify a specific molecular target that will guide future development of new therapeutic strategies.

Public health relevance
RELEVANCE: Over one-third of patients with epilepsy do not respond to the available drugs. One option for these patients is the ketogenic diet, which significantly decreases seizures in one half of patients who use it. However, essentially nothing is known about the anticonvulsant mechanisms involved. This proposal pursues a potential underlying mechanism of the ketogenic diet in epilepsy and is expected to identify a specific molecular target that will guide future development of new therapeutic strategies.